Integrated Food Safety System Online Research and Collaboration Development

INTEGRATED FOOD SAFETY SYSTEM ONLINE RESEARCH AND
COLLABORATION DEVELOPMENT: PROJECT SUMMARY
The Association of Food and Drug Officials (AFDO) will support the continued
development and promotion of innovative information sharing and research tools hosted
on the Integrated Food Safety System (IFSS) collaboration/research portal which will
continue to strengthen federal collaboration with state, local, tribal, and territorial (SLTT)
partners to advance FDA’s implementation of the Food Safety Modernization Act
(FSMA). AFDO has represented state regulatory food programs since 1896 and brings
an unparalleled team of technical and regulatory experts with deep institutional
knowledge of food safety and public health programs. The Principal Investigator and
project team include experienced professionals with backgrounds in state food safety
programs, laboratory systems, outbreak response, and digital infrastructure
development. Project management will benefit from an established infrastructure that
includes real-time project tracking and a diverse and engaged network of federal and
SLTT partners, whose input ensures alignment and relevance to the IFSS.
Major activities under this agreement include:
• Enhancing and maintaining the FoodSHIELD platform to support interagency
communication, data sharing, and regulatory coordination;
• Continued development of the Information Disclosure Portal and ongoing
maintenance of existing legacy portals and user-requested buildouts;
• Facilitating stakeholder-driven enhancements to FoodSHIELD through agile
development and continuous feedback;
• Improving FoodSHIELD metrics to identify cost-savings, user engagement, and
opportunities for operational efficiency for long-term platform sustainability
• Providing training and support resources to SLTT partners to improve regulatory
capacity and program conformance;
• Promoting mutual reliance and collaboration through shared tools, best practices,
and standardized training content;
• Supporting proficiency testing and laboratory accreditation efforts to strengthen
analytical capabilities;
• Advancing public health initiatives through collaborative workgroups that are
aligned with national food safety goals and that leverage interagency resources.
Through these efforts, AFDO will continue to build a secure, scalable, and cost-effective
digital infrastructure that empowers regulatory agencies and public health professionals
to work smarter, share knowledge, and protect the food supply.

Public health relevance
INTEGRATED FOOD SAFETY SYSTEM ONLINE RESEARCH AND COLLABORATION DEVELOPMENT: PROJECT NARRATIVE The Association of Food and Drug Officials (AFDO) will continue advancing a nationally Integrated Food Safety System (IFSS) through continued strategic enhancement and operational support of the FoodSHIELD platform under this cooperative agreement. Building on a strong legacy of collaboration with FDA and state, local, tribal, and territorial partners, AFDO will advance interagency coordination, regulatory program standards, and access to tools supporting outbreak response, inspections, laboratory testing, and training. FoodSHIELD offers a secure, centralized environment for communication and collaboration, through its customizable portals and data-sharing capabilities. AFDO will support continued development of key portals such as Manufactured Food Regulatory Program Alliance, Produce Regulatory Program Standards Alliance, and the Information Disclosure Portal, using an agile, stakeholder- informed methodology to implement scalable, cost-effective enhancements. These efforts will remove barriers to collaboration, leverage existing infrastructure, and capitalize on the platform’s scientific and regulatory strengths to empower food safety and public health professionals to work more efficiently and effectively.